Impact of Cannabinoid Across the Lifespan (ICAL)

ICAL ADMINISTRATIVE CORE: SUMMARY
This is a resubmission of the renewal application for the NIDA Center of Excellence, Impact of
Cannabinoids Across the Lifespan (ICAL). The Center tests the hypothesis that non-physiological
activation of the endocannabinoid system during adolescence – caused by exposure to D9-
tetrahydrocannabinol (THC) – initiates a reprogramming of the molecular processes that govern this
system, ultimately producing persistent abnormalities in synaptic plasticity and behavior. ICAL’s
Administrative Core serves as the organizational hub for ICAL’s scientific and programmatic activities.
In its first 4-year funding period, the Core: (a) organized two international symposia with
>1800 registrants from 127 global locations; (b) hosted multiple workshops, webinars, and
student-directed teaching activities; (c) supported and/or trained 47 undergraduate students
(22 from underrepresented minorities, URM), 9 graduate students (5 from URM), and 5
postdoctoral scholars (2 from URM); and (d) contributed to the establishment of a new NIDA-
funded T32 Training Program in Substance Use and Use Disorders (PIs: Wood and Piomelli).
If renewed, the Core will continue to oversee and integrate the activities of ICAL’s research projects,
shared research cores, pilot core, and outreach programs. The Core director, D. Piomelli, is
Distinguished Professor in the Departments of Anatomy and Neurobiology, Biological Chemistry and
Pharmaceutical Sciences, the Louise Turner Arnold Chair in the Neurosciences, and director of the
UCI Center for the Study of Cannabis. The core co-director, M. Wood, is Professor and Chair in the
Department of Neurobiology and Behavior, and director of the Irvine Center for Addiction
Neuroscience. In the previous funding period, Piomelli and Wood assembled an External Advisory
Group (EAG) composed of leaders in the field of cannabinoid research and addiction neuroscience,
who have agreed to continue serving if ICAL is renewed. With support from an Administrative
Specialist acting as Center Coordinator, Piomelli will manage workflow, coordinate meetings,
facilitate interaction with ICAL’s SC and EAG and other stakeholders, track and report the Center’s
progress, identify challenges, and implement solutions. The Center Coordinator will also be
responsible for budget management and reporting, drafting, and maintaining of animal protocols,
generating content for ICAL’s website and other communications, and for coordinating and
scheduling all meetings, seminars, workshops, and outreach events. The combined expertise of the
Administrative Core’s leadership and staff will ensure that ICAL’s scientific and programmatic goals
are met and disseminated to cannabinoid researchers as well as to the scientific community and the
public.